Conduct of studies to evaluate the toxic and carcinogenic potential of alpha-pinene, sulfolane and MWCNT in laboratory animals

The goal of this project is to provide support of the Division of Translational Toxicology (DTT) hazard identification activities targeted toward the prevention of diseases or adverse effects caused by environmental exposure to chemical or physical agents. Toxicity testing is an important aspect of public health research in that it serves to identify chemicals that are hazardous to human health. Proper conduct of toxicology studies is required to ensure that the resulting data are reliable. This project involves the conduct of toxicity and carcinogenicity studies in rats and mice to 3 different test agents: alpha pinene (exposure by whole-body inhalation), sulfolane (exposure in drinking water) or MWCNT (exposure by whole body inhalation). Alpha-pinene is found in turpentine and in flavorings and fragrances. Humans may be exposed via the air they breathe, through use of personal care and cleaning products as well as in lumber processing and building activities. Sulfolane is a drinking water contaminant, of particular concern in the state of Alaska. MWCNT are a nanomaterial used in the production of a number of electronic devices. The data from these studies will be used in the development of sound, scientific conclusions about the potential toxicity and carcinogenicity of these test articles in rats and mice and ultimately supports the mission and goals of DTT and risk assessment activities of other federal agencies. In addition, the public can be adequately informed about risk factors arising from exposure to these test agents.
Keywords: toxicity, carcinogenicity, inhalation, drinking water, lung, alpha-pinene, MWCNT, nano, sulfolane